Administrative Core

SUMMARY: The Administrative Core (Core A) will continue to provide the mechanism and structure to plan,
evaluate, and manage the Projects and Cores in this Program Project (PPG). The goals of Core A are to provide
scientific, programmatic, and fiscal leadership and facilitate communication between all researchers to ensure
that the Projects fulfill the goals set forth in the proposal and meet the administrative and financial requirements
of the NIH, the University of Rochester, and the four other institutions involved, Harvard Medical School, Albert
Einstein College of Medicine, Washington University and Mount Sinai. Core A will facilitate monthly meetings by
videoconference and annual face-to-face meetings. The Core will also be responsible for the communication
between the PPG and the NIH. Further, the Core will ensure that the results of each Project are disseminated in
a timely manner for the benefit of the scientific community. To this end, Core A will facilitate the submission of
joint publications and will oversee data management by Core C including maintaining a database for all biological
specimens and data generated by the Projects and Cores. Core A will also oversee the management of the
Degu Resource by Core B and facilitate the interaction between Cores B and C in building the website for Degu
resource to make it accessible for the community. Finally, Core A will organize the biennial reviews by the
external Scientific Advisory Board.